Anesthesiology Research Training

Project Summary
The proposed program will provide support for postgraduate research training within the Department of
Anesthesiology within the Health Sciences Division of Columbia University. Qualified applicants will have
committed to or be enrolled in postgraduate training in anesthesiology. The candidate pool is largely derived
from an established research residency track (Apgar Scholars Society). The program will provide for four
trainees, typically two in their fifth and two in their sixth postgraduate years. Research opportunities are
offered by twenty one participating faculty members with proven records of success in the training of
postdoctoral fellows, both within the Department of Anesthesiology as well as from nine collaborating
departments, three in basic sciences: Pharmacology, Physiology and Cellular Biophysics, and the
multidisciplinary Center for Neurobiology and Behaivor; and six clinical departments/divisions: Preventive
Medicine, Pulmonary Medicine, Cardiology, Endocrinology, Neurosurgery, and Psychiatry. Research areas
include, but are not limited to, modulation of neurotransmission by excitatory amino acids; molecular
mechanisms of neuronal plasticity in chronic pain; structure/function of ligand gated ion channels; anesthetic
and alcohol modulation of gene expression; smooth muscle cell signaling; adenosine receptor physiology;
mechanisms of organ injury and protection from ischemia-reperfusion injury; molecular mechanisms of airway
remodeling in chronic lung disease; clinical and basic studies in anesthetic-mediated developmental
neurotoxicity, biomarkers of clinical organ injury, and epidemiology studies of clinical outcomes. With the
continued support of the Department of Anesthesiology following training, this program will lead to the
establishment of independent physician-scientistst modern methods and techniques to help meet the research
needs of the specialty of anesthesiology in the twenty first century.

Public health relevance
Narrative The proposed program will provide support for postgraduate research training in the Department of Anesthesiology within the Health Sciences Division of Columbia University to qualified applicants who have committed to or are enrolled in postgraduate training in anesthesiology. The goal of this training is to provide for the next generation of physician-scientists and researchers who will seek to improve medical care in areas relevant to perioperative care, palliative care, acute and chronic pain and health services delivery.